Center of Integrated Biomedical and Bioengineering Research (CIBBR)

PROJECT SUMMARY/ABSTRACT (OVERALL CORE)
The University of New Hampshire’s (UNH) first COBRE: Center of Integrated Biomedical and
Bioengineering Research (CIBBR) has substantially improved the biomedical and bioengineering research
environment during Phase 1. These gains can be attributed to four major advancements: (a) strategic
investments in Research Project and Pilot Project funding for 13 early-stage (plus 4 mid-career) UNH faculty
conducting biomedical and bioengineering research; (b) dedicated mentoring of these faculty by the CIBBR
Leadership Team and External Scientific Mentors; (c) major gains in research infrastructure, including the
acquisition of state-of-the-art instrumentation and creation of the Molecular and Cellular Phenotyping Core,
and; (d) the amplification of this infrastructure by institutional contributions to new instrumentation and addition
of new technical staff within UNH’s University Instrumentation Center.
The overall goal of this Phase 2 application is to further advance biomedical and bioengineering research
by implementing a faculty “cluster hire” that—together with a new Data Science Core and other enhancements
to research infrastructure—will accelerate rigorous, multidisciplinary research at UNH to advance the
translation of biomedical discoveries to applied solutions that improve human health. We will accomplish this
through the following specific aims: Aim 1. Expand and strengthen our Center’s research, administrative
operations, and evaluation programs to further enhance the research environment at UNH for conducting NIH-
funded biomedical and bioengineering research. Aim 2. Create a critical mass of NIH-funded investigators
through recruitment of early-stage investigators supported by enhanced multi-component mentoring and career
development programs for CIBBR investigators.
Upon completion of Phase 2 of CIBBR, we will have strategically increased the biomedical research
capacity at UNH through “cluster” hiring of both early-stage investigators and senior biomedical and
bioengineering researchers and improved and expanded the mentoring of CIBBR faculty. This will be
accompanied by the creation of a Data Science Core and acquisition of additional research instrumentation for
the Molecular and Cellular Phenotyping Core. These actions will have a powerful and sustained impact on
biomedical and bioengineering research at UNH by expanding the number of faculty performing NIH-funded
research. Enhancing the capacity of UNH and external researchers to apply multidisciplinary and multi-omics
approaches will increase our knowledge of basic biomedical science and bioengineering, expedite the
development of clinically relevant diagnostic tools and treatments, and advance biomedical workforce training
capacity in the State of NH.

Public health relevance
The University of New Hampshire’s first COBRE: Center of Integrated Biomedical and Bioengineering Research (CIBBR) has substantially improved the biomedical and bioengineering research environment during Phase 1, as evidenced by the number of research project grant awards and publications by CIBBR investigators, the career advancement of CIBBR faculty, and major investments in biomedical research infrastructure. Building upon these accomplishments, the overall goal of CIBBR in Phase 2 is to expand the Center’s research portfolio through continued hiring of new biomedical and bioengineering faculty, creation of a new Data Science Core, acquisition of new instruments in conjunction with a business plan, and enhancements to the mentoring program and administrative operations. These actions will have a powerful and sustained impact on biomedical and bioengineering research at UNH by increasing our knowledge of basic biomedical science and bioengineering, expediting the development of clinically relevant diagnostic tools and treatments, and advancing biomedical workforce training capacity in the state of New Hampshire.